The role of Kmt2c/MLL3 in hematopoietic stem cell self-renewal, commitment and exhaustion

PROJECT SUMMARY
The overarching goal of this proposal is to understand how two highly homologous epigenetic regulators, MLL3
and MLL4, coordinate critical cell fate decisions during adult blood development. Considerable prior work has
gone into understanding the transcription factor networks that coordinate blood development, particularly at the
level of hematopoietic stem cells (HSCs), multipotent progenitors (MPPs), and lineage committed progenitors.
These networks are important because they maintain blood and immune system homeostasis, and they touch
on essentially every human blood disorder. Like transcription factors, epigenetic regulators are also critical for
blood development and homeostasis, as evidenced by the fact that they are frequently mutated in clonal
hematopoiesis and various leukemias. However, unlike transcription factors – which often have well-
characterized DNA binding motifs, binding partners, and cis-regulatory elements – we currently have only limited
insight into how epigenetic regulators are deployed to effect specific cell fate decisions.
The case of MLL3 and MLL4 illustrates both the importance of epigenetic regulation in blood development and
our limited understanding of their underlying mechanisms. MLL3 and MLL4 each nucleate a multiprotein,
chromatin-bound complex called the Complex of Proteins Associated with SET1(COMPASS). MLL3 and MLL4
are highly homologous, and both bind enhancer elements to promote gene expression. However, the proteins
have very distinct functions in HSCs and MPPs despite their shared homology. MLL4 maintains HSC self-renewal
capacity while opposing myeloid differentiation, whereas MLL3 antagonizes HSC self-renewal while promoting
differentiation. These observations create a unique opportunity to learn how structurally similar epigenetic
regulators can be selectively recruited to discrete cis-regulatory elements to convey specific hematopoietic fates.
In new preliminary studies, we made additional discoveries that shape the aims of this proposal. Specifically, we
discovered that MLL3 and MLL4 have redundant roles in licensing HSC identity and myeloid potential despite
their apparently antagonistic functions. Inactivating both proteins causes HSCs/MPPs to adopt a B-lymphoid
primed state. We propose the following two aims to investigate the underlying causes of these cell fate changes.
Aim 1 is to define mechanisms by which MLL3 and MLL4 license HSC identity, as well as mechanisms that
account for their distinct functions in HSC self-renewal and differentiation. Aim 2 is to define MLL3/4 COMPASS-
independent mechanisms of B-lymphoid development. We will use a combination of genetically engineered mice
and various genomic and proteomic techniques to identify cis-regulatory elements, transcription factors and
chromatin binding proteins that mediate MLL3- and MLL4-specific cell fates. In each aim, we will focus on
understanding the regulatory logic that defines MLL3/4 COMPASS usage or COMPASS independence. The
proposed work will create a paradigm for understanding transcription factor/co-factor interplay during blood
development.

Public health relevance
PROJECT NARRATIVE Blood production requires precise regulation by transcription factors and epigenetic regulators, including transcriptional co-factors MLL3 and MLL4. Mechanisms that govern co-factor usage at one gene but not another remain ill-defined, yet they are critical for maintaining blood homeostasis. We propose experiments to define the mechanisms that govern usage of MLL3 and MLL4 to promote appropriate blood production.